Brucella induces STING-mediated Guanylate-Binding Protein expression and Unfolded Protein Response: Balancing Bacterial Elimination, Inflammation and Disease

1 Summary
2 Brucellosis is one of the world’s most frequent zoonotic diseases with over 500,000
3 new human infections every year. Human brucellosis in Brazil represents an additional
4 economic burden due to health care costs and has a major social impact due to
5 decreased productivity and quality of life and occasionally incapacitation or death.
6 Brucella abortus strain 19 vaccine is the principal vaccine used to prevent transmission
7 of brucellosis from cattle to humans worldwide and in Brazil and it is not a select agent.
8 The mechanisms that mediate protection by strain 19 are poorly understood. Host
9 mechanisms of innate immunity induced by the vaccine that control infection remain
10 obscure. Additionally, the vaccine contains several properties that are inhibitory to host
11 immunity. We have demonstrated that B. abortus, bacterial DNA and LPS leads to
12 inflammasome activation via STING/GBP (guanylate-binding protein) axis that limits
13 Brucella replication. In contrast, B. abortus induces the Unfolded Protein Response
14 (UPR) that favors Brucella survival in the host. Therefore, our long-term goal is to
15 resolve the black box of how Brucella activates innate immune components that
16 results in host resistance versus bacterial subversion of the immune response.
17 Based on these compelling preliminary data, we propose to test the central hypothesis
18 that Brucella abortus strain 19 activates protective innate immune mediators via
19 STING/GBP pathway and triggers the UPR to secure intracellular replication. Our
20 specific aims are: 1) To define which STING-mediated guanylated-binding proteins
21 (GBPs) are important to release bacterial DNA and LPS into host cells to activate
22 inflammasome receptors; 2) To determine whether the Unfolded Protein
23 Response (UPR) induced by Brucella regulates macrophage polarization to
24 facilitate bacterial persistence; 3) To determine whether the transcription factor
25 HIF-1α-dependent metabolic changes in macrophages induced by Brucella affect
26 inflammasome activation and bacterial clearance. We believe that our approach will
27 shed light on the mechanisms of immunity and/or pathogenesis of this important
28 human and animal pathogen. Finally, the investigators on this proposal have a strong
29 track record in brucellosis research and a unique combination of key expertise in
30 microbiology, innate immunity and cell biology.

Public health relevance
Project Narrative Brucellosis is one of the world’s most frequent zoonotic diseases with over 500,000 new human infections every year. This proposal defines the pathways of innate immune activation or inhibition by Brucella abortus strain 19 vaccine. Identifying the mechanisms of activation or inhibition of innate immune responses used by strain 19 will determine the issues with the current vaccine and suggest changes to enhance its efficacy and disease control.